IMMUNE GLOBULIN INTRAVENOUS (HUMAN) 5% SOLUTION

The purpose of this study is to see whether there is any difference in the levels of immunoglobulin in subject's blood after an infusion of IGIV 5% liquid compared to lyophilized IGIV. The safety of the IGIV 5% liquid will also be studied.